Novel approaches to understanding precursor protease autoprocessing in intact viruses

Project Abstract
This project aims to use two highly novel and powerful assays to investigate HIV-1 protease (PR) precursor
dimerization and autoprocessing in the context of intact viruses. In contrast to studies of the mature PR, little is
known about how the precursor PR is activated and regulated, particularly under physiological conditions. We
have developed a flow virometry-based assay that enables high-throughput analysis and sorting of individual
viral particles and provides a rapid and efficient method for identifying determinants of precursor PR activation.
To complement this method, we have also developed a selective reaction monitoring-mass spectrometry
(SRM-MS) assay that allows simultaneous monitoring of all Gag and Gag-Pol cleavage sites with extremely
accurate quantification of cleavage site processing efficiency. We will use these assays to:
Aim 1: Identify determinants of precursor PR autoprocessing in the context of intact viruses.
Aim 2: Determine the timing of PR activation in relation to budding, and define how premature activation of
precursor PR activity is regulated.
Aim 3: Evaluate how drug resistance and accessory mutations affect processing, budding, and the infectivity
of viruses under physiological conditions.

Public health relevance
Project Narrative This project seeks to use novel and powerful assays that we have developed to address important and unresolved questions surrounding HIV-1 protease (PR) activation. We will identify the viral and host determinants of PR activation, assess the timing and order of activation during virus budding, and assess the effect of PI resistance mutations on PR activation in viruses. This project will provide unprecedented insights into precursor PR activation under physiological conditions, generating important translational insights and applications.